2023 Applied and Environmental Microbiology Gordon Research Conference and Seminar

Project Summary / Abstract
The 2023 Applied and Environmental Microbiology Gordon Research Conference (AEM GRC) will explore the
core principles for understanding and predicting the role of microbes in ecosystem functioning, from human
holobionts to aquatic ecosystems. The fundamental mechanisms that regulate microbiome-host-environment
interactions lie at the heart of the sustainable control of microbial dynamics for therapeutic and environmental
interventions. Despite being a well-established conference, AEM remains a forefront topic, bridging the traditional
boundaries of many fields. It drives infectious disease outcomes and the susceptibility of microoorganisms to
antibiotics as well as beneficial processes such as the development of antimicrobials and probiotics. Importantly,
common mechanisms of microbiome-host-environment interactions link these apparently diverse processes and
a key aim of the conference will be to bring together fields that do not normally interact strongly. Further, the
meeting will highlight a wide range of experimental approaches from deep sequencing to probing single cell
phenotype and bring together scientists of all career stages and backgrounds, from academia to industry. The
GRC will comprise 27 invited speakers with 24 slots for talks to be selected from the abstracts as well as an
interactive poster session. In addition, the GRS, which precedes the main conference will have further oral and
poster presentation opportunities specifically for graduate students and post-docs, as well as a career panel
discussion. A `power hour' during the main meeting will focus on the challenges facing women and
underrepresented minorities in science. We aim to foster an interactive, friendly environment in which ideas can
be freely exchanged independently of background or seniority. To that end, the sessions and working meals will
be supplemented with a vigorous social program to foster these interactions. The GRC program will be organized
into nine morning and evening sessions entitled: (1) Core principles that govern life (Keynote session); (2)
Biodiversity and ecosystem function; (3) Ecoengineering, applications, and emerging contaminants; (4) Ecology
and evolution of holobionts; (5) Transitioning human microbiome research into health outcomes; (6) Probing
microbial phenotypes in situ; (7) Microbial mediation of biogeochemical cycles; (8) Microbes and climate change
and (9) Symbiosis in ecosystems. The GRC and GRS will thus promote exchange of the latest ideas and
techniques in the broad field of applied and environmental microbiology, generating new ideas and cross-field
collaborations while enhancing and promoting the careers of the next generation of scientists in this dynamic
and exciting field.

Public health relevance
Project Narrative Applied and environmental microbiology (AEM) characterizes the in situ functioning of microorganisms and has wide ranging impacts from the development of a predictive understanding of microbiome-host-environment interactions that drive human health outcomes to improving strategies to combat antibiotic resistance. This meeting will bring together scientists from a wide range of disciplines to discuss the fundamentals of applied and environmental microbiology promoting cross-fertilization of ideas, collaboration, and the identification of new approaches for the sustainable control of microbial dynamics for therapeutic and environmental interventions.